Role of Membrane Trafficking in Epithelial Homeostasis

Epithelial cells play critical roles in many organs and are responsible for elemental processes
such as nutrient uptake and waste product secretion. To fulfill these functions, they polarize their
plasma membrane into apical and basolateral domains. To maintain tissue homeostasis, epithelial
cells must continuously sort newly synthesized and internalized surface receptors to the correct
target domain. And after tissue damage, epithelial cells must correctly migrate into the wound and
re-colonize the wound area. Loss of polarity is associated with numerous diseases including
metastatic cancer, polycystic kidney disease, and Crohn’s disease. How epithelial cell polarity is
regulated is thus an important cell biological question with profound implications for human health.
Our work identified the epithelial cell-specific clathrin adaptor complex AP-1B as crucial for
polarized recycling of cargos to the basolateral domain. Cargos that depend on AP-1B for
basolateral localization include important signaling receptors such as epidermal growth hormone
receptor who’s missorting to the apical domain has been implicated in cancer and polycystic
kidney disease, and toll-like receptor 3 whose missorting results in chronic inflammation. A major
unresolved question in the field is how AP-1B uniquely functions in epithelial cells, and why its
close cousin AP-1A mostly fails to substitute. Our previous work suggested that AP-1B changes
the organization of recycling endosomes (REs) to accommodate AP-1B’s function in basolateral
sorting. Only AP-1B but not AP-1A localizes in REs where it triggers the formation of a lipid domain
enriched in PI(3,4,5)P3, and facilitates the recruitment of accessory factors including a vesicle-
tethering complex (the exocyst) and a lipid kinase (PIPKI-90). We recently showed that AP-1B
expression reduced the speed of collective cell migration after monolayer wounding, a novel
function independent of basolateral sorting. We will test the central hypothesis that AP-1B plays
dual roles in establishment and maintenance of epithelial monolayers by 1) directing cargos to
the basolateral membrane by generating a sorting platform in REs at steady-state and 2) during
cell migration by modulating the availability of focal adhesion molecules at the plasma membrane.
We will test this hypothesis in our proposed experiments by using state-of-the-art imaging
techniques including live TIRF microscopy in combination with photoactivation and unbiased
screens including BioID and mass spectrometry to complement innovative cell biological and
biochemistry approaches to: 1. Determine how AP-1B generates a basolateral sorting platform,
and 2. Determine how AP-1B controls cell migration. Our studies will define new mechanisms
governing the organization of polarized epithelial cells at steady-state and during cell migration.

Public health relevance
Epithelial cell function is crucial for the human body. Many diseases such as metastatic cancer manifest through aberrant surface delivery of proteins in epithelial cells or overgrowth of epithelial tissues. The proposed research will provide insights into fundamental regulatory processes that govern epithelial polarity, which is necessary to enable development of novel strategies to treat or to prevent human diseases.